Medical Student Alcohol Research Internship

ABSTRACT
In order to effectively address the need for physician scientists who are trained to conduct biomedical
research, we propose a short-term research training program for pre-matriculating and matriculated medical
students at LSUHSC-New Orleans. This Summer Internship Program (SIP) will support five students to work
with researchers within the Department of Ophthalmology and the Lion’s Eye Center and is designed to
cultivate their interest in careers focused on eye disease research. We have identified many faculty mentors
who are working on both clinical and basic science studies of alcohol abuse. Students will conduct intensive
hands-on clinical or basic science research for 10 weeks in the summer, working with ARC faculty. Those
students who participate for a second summer (pre-matriculated students) will act as peer mentors to incoming
students, thus providing an important mentoring component to the program. The goals of this program include:
1) to provide medical students with research experiences; 2) to provide students with strong career and
research mentoring; 3) to increase the participation in research by women and minority students; 4) to provide
summer interns with the career skills they will need to succeed in academic medicine. In addition to their
research experience, students will receive didactic training on: lab safety, responsible conduct of research,
HIPPA, use of animals in research, skill development in writing abstracts and presenting research results (oral
and poster presentations). At the end of the summer, students will give a poster presentation at the Medical
School Research Day. The Dean’s office will also help support their travel to present their data at national or
regional meetings. We will work to recruit 10% underrepresented minority participants, reflecting the
demographics of the LSU medical school class. In order to determine the impact the program has on individual
participants, summer interns will complete Goals Attainment Scales (GAS) as well as Research Self Efficacy
(RSE) surveys. GAS has been shown to be a valuable and flexible technique for the evaluation of summer
research training programs. RSE is a major predictor of career choice and performance. We will also conduct
formative and summative evaluations concerning the entire program, in order to determine what programmatic
changes may be needed and to tailor the program to better meet the needs of the students. Lastly, working
with the Office of Student Affairs, we will implement a career tracking system which will measure the long-term
impact of their summer experience on career choices and research participation, thus quantifying the long-term
impact of this program. This program will not help to create the next generation of alcohol researchers but also
will prepare physicians to treat the variety of alcohol-related diseases.

Public health relevance
Project Narrative We propose a short-term research training program for medical students in research labs and clinics. The Medical Student Alcohol Research Program is designed to cultivate students' interest in research careers by preparing them to work on research projects on alcohol abuse and alcohol related diseases. This program will help to create the next generation of Louisiana physician researchers who are prepared to conduct the translational research that can transform basic science discoveries into new clinical therapies.